Development of a Virtual Health Care Platform to reduce emergency re-hospitalizations in Heart Failure Patients transitioning from hospital to home

Abstract-Summary
The overall purpose of this SBIR Phase 1 project is the development and test of nucleusRx’s (NRx) Virtual
Care Platform and remote intervention tool targeting post-acute care Heart Failure (HF) patients, providing a
safe and cost-effective discharge transition plan from the hospital to home. HF is the largest common cause for
disease-related hospitalization in the US (estimated 1 million/year) and has a mortality rate of 42% within 5
years of initial diagnosis. An additional 4.1 million emergency visits, 3.4 million hospitalizations, and 231,000
deaths have HF as a comorbid or contributing cause. The economic impacts from heart failure, both direct and
indirect, are estimated to hit $70 billion by 2030. Despite many HF re-hospitalizations being considered
preventable, HF related hospitalizations among older adults and Medicare beneficiaries have the highest
readmission rate of any medical condition.
Currently, there is no remote monitoring platform available in the market providing real-time, 24/7 visibility of
patient’s health and treatment compliance when discharged from the hospital to home after an acute episode
of HF. The American Heart Association (AHA) recommends the implementation of the Guideline Directed
Medical Therapy (GDMT) for post-acute HF treatment, which consists of a rapid initiation of four pillar drugs to
treat HF patients during hospitalization, and its continuation at home after discharge. However, over a 12-
month period after initial diagnosis, less than 1% of HF patients in the US receive optimal GDMT doses. There
is also no one fixed agreed guideline of introduction of all GDMT medications for the treatment of HF within 30
days of acute HF hospitalizations, although there is a general consensus of the need to initiate all four pillar
therapies while the patients are in the hospital or during the first week of discharge to home.
Our complete solution, nucleusRx’s Virtual Care Platform, consist of a physical device -a specially designed pill
dispenser and accompanying blood pressure monitor and weight scale- and an interconnected software
platform, all connected to patient’s mobile phone. The platform works in an integrated manner to enable
healthcare providers to implement a safe discharge transition plan from hospital to home, while allowing rapid
GDMT dose optimization remotely with total visibility on patient health status and therapy compliance. In this
project, work is proposed in a short (28 days) clinical feasibility trial to determine the effectiveness of
nucleusRx platform functionalities. HF patients discharged from the hospital will be provided with the device
and access to a patient companion digital app with information on their health and medication compliance,
while doctors and other caregivers will monitor patients’ health status through a specially designed computer
dashboard interface. Clinical assessments, performed as part of the second objective of the project, will help
determine the clinical impact of the Virtual Care Platform by assessing medication compliance and satisfaction
and usability of the platform from the point of view of both patients and providers. Improvement of the software
user interfaces based on feedback and experiences from patients, caregivers and providers, and integration of
the Virtual Care Platform with the major EPIC electronic health record software used in most hospitals are the
final objectives in the project.

Public health relevance
Project Narrative Heart Failure (HF) is the second highest cause for disease-related hospitalization in the US (~1 million/year), and has a mortality rate of 42% within 5 years of initial diagnosis. With ~6.2 million patients in the US, and despite being considered preventable, many HF related hospitalizations among older adults and Medicare beneficiaries have the highest readmission rate among all conditions, so reduction of hospitalizations is now a national priority for Medicare. To help reduce these re-hospitalizations, in this project we will develop a virtual intervention tool to help healthcare providers monitor patient health and adjust medication dose in real-time.